NEDD9 and Chromium(VI) Carcinogenesis

Cr(VI) compounds are carcinogenic to humans. The underlying mechanism remains unknown. Neural
Precursor Cell Expressed Developmentally Down-regulated Protein 9 (NEDD9), a multi-domain scaffolding
protein, is crucial for tumorigenesis. High expression of NEDD9 is correlated with advanced clinical stage of
non-small cell lung carcinomas (NSCLC). Autophagy is a key regulator that maintains p62 at desired levels.
Upregulation of p62 is associated with various carcinogenic processes. Our preliminary studies show that in
Cr(VI)-transformed cells, NEDD9 is upregulated, and autophagy is impaired, resulting in the upregulation of
p62, Nrf2, and Bcl-2. Knockdown of NEDD9 decreases p62 and Nrf2 expression and reduces the malignancy
of Cr(VI)-transformed cells. Knockdown of p62 or Nrf2 suppresses tumorigenicity of Cr(VI)-transformed cells.
Overexpression of p62 in BEAS-2B cells causes malignant cell transformation and tumor growth. Among the
six main domains/regions of p62, the TNF receptor-associated factor 6 (TRAF6)-binding domain (TB) binds to
and phosphorylates TRAF6, leading to NF-κB activation, and the Keap-interacting region (KIR) binds to Keap1,
causing constitutive Nrf2 activation. HIF-1α, a key regulator of angiogenesis, is upregulated in Cr(VI)-
transformed cells and knockdown of NEDD9 reduces its expression. The central hypothesis is that in normal
cells ROS generated by Cr(VI) overwhelms the protection of autophagy, causing NEDD9 upregulation,
eventually malignant cell transformation, that in Cr(VI)-transformed cells NEDD9 upregulation impairs
autophagy, causing upregulation of p62, which then activates NF-κB and Nrf2, and subsequently upregulation
of its downstream anti-inflammatory and anti-apoptotic proteins, and that NEDD9 positively regulates HIF-1α,
resulting in tumorigenesis of Cr(VI)-transformed cells. Aim 1 will test the hypothesis that chronic exposure of
cells to Cr(VI) generates ROS and induces autophagy, that autophagy protects against Cr(VI)-induced
malignant transformation by decreasing ROS level through facilitating mitochondrial turnover, and that ROS
generated by Cr(VI) overwhelms the protection of autophagy, resulting in NEDD9 upregulation and eventually
malignant cell transformation. We will investigate the protective role of autophagy against Cr(VI)-induced cell
transformation via the decrease of ROS through facilitated mitochondrial turnover and the role of NEDD9
upregulation by Cr(VI)-induced ROS in malignant cell transformation. Aim 2 will test the hypothesis that in
Cr(VI)-transformed cells upregulation of NEDD9 impairs autophagy, causing accumulation of p62,
subsequently activation of NF-κB and Nrf2, and that NEDD9 upregulates HIF-1α, leading to increased cell
survival, angiogenesis, and tumorigenesis. We will investigate that NEDD9 upregulates p62, then NF-κB
activation and constitutive Nrf2 activation, and its downstream inflammatory and anti-apoptotic proteins, as well
as HIF-1α in tumorigenesis of Cr(VI)-transformed cells. Aim 3 will investigate the role of NEDD9 in the
mechanism of Cr(VI) carcinogenesis using NEDD9 wild-type and knockout animals exposed to Cr(VI).

Public health relevance
NARRATIVE Cr(VI) compounds are carcinogenic to humans. This study investigates the role of NEDD9, a multi-domain scaffolding protein, in the mechanisms of malignant cell transformation and of tumorigenesis induced by Cr(VI) at the cellular and whole animal levels. If aims are achieved, this study will demonstrate that in normal cells ROS generated by Cr(VI) upregulates NEDD9, leading to malignant cell transformation, and that in Cr(VI)- transformed cells upregulation of NEDD9 elevates p62 and HIF-1α, subsequently activates NF-κB and Nrf2, leading to increased survival of Cr(VI)-transformed cells and tumorigenesis.